TRAF3IP2 as a Proinflammatory Mediator of Alcohol-related Cardiomyopathy

Abstract
This NRSA F30 fellowship will provide the groundwork that will prepare the applicant for a career
in academic medicine as a cardiothoracic anesthesiologist. Much of the applicant’s career
development will come from work in alcohol and cardiovascular-related research. Alcohol-related
Cardiomyopathy (AC) manifests in humans after excessive alcohol consumption and is
characterized by ventricular dilation and cardiac function impairment. During cardiac inflammation
and injury, fibroblasts differentiate into myofibroblasts, which are larger in cell size and express
higher levels of collagens and their crosslinking enzyme lysyl oxidase (LOX). Here, the role of
TRAF3IP2, a proinflammatory cytoplasmic adapter protein, in the pathogenesis of AC is explored.
Preliminary data indicates that exposure of naïve cardiac fibroblasts (CF) to alcohol induces
TRAF3IP2 protein expression in a time- and dose-dependent manner. In our studies, we will
investigate whether i) alcohol-induced cardiac fibroblast activation, and proinflammatory cytokine
and extracellular matrix expression are dependent on TRAF3IP2 and ii) global TRAF3IP2 gene
deletion prevents alcohol-induced cardiac inflammation, fibrosis, and dysfunction.
The cellular mechanism underlying alcohol-induced cardiac inflammation and fibrosis are
investigated using both in vitro and in vivo alcohol exposure. In vitro, TRAF3IP2 is targeted using
naïve CF from wild-type mice transduced with TRAF3IP2 shRNA and CF isolated from
homozygous TRAF3IP2 knockout mice. In vivo, TRAF3IP2 is targeted using global TRAF3IP2-
knockout mice on a 30-day Lieber-DeCarli or isocaloric control liquid diet based on the
chronic+binge model. Endpoint measures include induction of proinflammatory and profibrotic
pathways.
Using the chronic+binge model of AC, TRAF3IP2-KO and littermate controls are exposed to
chronic alcohol consumption. Endpoints include assessment of cardiac function and chamber
dimensions by echocardiography and pressure-volume left ventricular catheterization. Markers of
inflammation and fibrotic measures include collagens I and III, LOX expression, left ventricle total
collagen, and histological assessment of interstitial fibrosis by PSR staining.
Ultimately, these studies may identify novel, therapeutic targets for the treatment of alcohol-
related cardiomyopathy. With the support of a strong mentoring team, completion of the proposed
research and training plan will ensure that the applicant is prepared for an impactful career as a
physician-scientist.

Public health relevance
Project Narrative This NRSA F30 fellowship will provide an invaluable and comprehensive training opportunity for a future physician scientist as he develops into an emerging leader in cardiovascular research. The proposed studies will investigate the mechanism of Alcohol-related Cardiomyopathy (AC) pathogenesis and focus on the contribution of a proinflammatory mediator TRAF3IP2. Findings from this research may uncover novel therapeutic options for those suffering from AC.